From Child Maltreatment to Violence Involvement: Life Course Pathways, Trajectories, and Patterns.

PROJECT SUMMARY/ABSTRACT
Significance. Childhood maltreatment is linked to lifelong negative consequences, including the perpetration
of violence in later life, a phenomenon often referred to as the "cycle of violence." While the heterogeneity
within this cycle is recognized, prospective longitudinal research examining the relationships between
childhood maltreatment, adolescent weapon involvement, and both weapon- and non-weapon-related violence
in adulthood remains limited. This proposal seeks to address this gap by analyzing an extended life span and
incorporating factors that may be developmentally shaped by childhood maltreatment and intertwined with
violence, such as neighborhood conditions, alcohol problems, and social isolation. Additionally, the study will
account for individual differences, risk factors, and social determinants of health to provide a more
comprehensive understanding of these dynamics. In doing so, it will enhance our understanding of the
pathways, trajectories, and patterns of weapon-related and non-weapon-related violence from a life-course
perspective. Research plan. The proposed research will leverage a unique 50-year longitudinal prospective
cohort study to assess the long-term consequences of childhood maltreatment and examine adolescent
weapon carrying, use, and threats (WCUT), as well as violent and criminal behavior in adulthood. The aims
are: (1) to examine whether child maltreatment (ages 0–11) increases the risk of weapon involvement in
adolescence (ages 12–17) and if this risk is independent of non-weapon-related violence; (2) to investigate the
onset and temporal order in the relationship between child maltreatment (ages 0 to 11) and subsequent WCUT
in adolescence (ages 12 to 17); (3) to assess the co-development of weapon and non-weapon violence
trajectories in adulthood (ages 18–51), and how child maltreatment (ages 0–11), adolescent WCUT (ages 12–
17), and other social determinants predict these trajectories; and (4) the reciprocal associations among
weapon and non-weapon violence, neighborhood conditions, alcohol problems, and social isolation over time
(ages 29 to 59). Career development plan The goal of this K99/R00 award is supported by a career
development plan designed to build upon and enhance the candidate’s skills to become an independently
funded researcher and complete the proposed project. The plan includes training in the following areas: (1)
subject-matter knowledge in violence prevention and injury science; (2) deepening expertise in causal
inference and longitudinal data analysis; and (3) developing the skills necessary to transition to independent
research. Environment and mentors: The research proposal and career development plan will be conducted
at Columbia University, supported by an outstanding mentorship team with substantial expertise in all areas
relevant to the project. Impact. This work fully aligns with the NICHD’s strategic plan by advancing the
understanding of child development, early exposures, and transitions to adulthood through a life-course,
interdisciplinary approach to inform future prevention and intervention strategies.

Public health relevance
PROJECT NARRATIVE The experience of childhood maltreatment can have lasting effects on health and behavior, including an increased risk of violence later in life. Adopting a life-course perspective, this research examines the relationship between childhood maltreatment, adolescent weapon involvement, and both weapon-related and non-weapon-related violence over time. It addresses key methodological limitations of previous studies by incorporating documented cases of child maltreatment, a matched control group, long-term follow-ups, multiple sources of data (self-reports and official records of violent and criminal behavior), and a comprehensive set of individual, social, and community factors.